Expanding the populations for the identification of genes and variants imparting susceptibility to age-related hearing loss using data from the All of Us Research Program

PROJECT SUMMARY/ABSTRACT
Age-related hearing loss (presbyacusis) is among the most common chronic conditions of aging
worldwide, is increasing at an alarming rate along with the older population, and constitutes a significant and
costly public health concern. Genetic factors are among its many etiologies and the high prevalence of age-
related hearing loss suggests that several fairly common alleles may play a significant role in its development
and progression. Alternatively, age-related hearing loss could result from one or more mutations in a single
gene. Recent work from the P50 Clinical Research Center (Experimental and Clinical Studies of Presbyacusis)
and others strongly suggests that both mechanisms are involved. However, no genetic risk factor has yet been
unequivocally identified and the lack of such information has impeded the development of screening assays to
identify individuals who are at high risk or require protection. Thus, in Project 1 of our Parent P50 Clinical
Research Center, a population-based cohort molecular genetic study was launched, taking advantage of whole
exome sequencing to provide information about genetic contributions to age-related hearing loss in general, as
well as to specific pathophysiologic phenotypes and biological pathways, thereby enabling the potential
application of existing treatments and development of new treatments. Comprehensive bioinformatic analysis
of exome sequence data from 532 well-characterized human subjects ≥55 years of age of non-Finnish
European (NFE) ancestry, selected from MUSC’s unique longitudinal database, has now identified a
substantial number of both common and rare variants as strong candidate genes for presbyacusis. In this
Administrative Supplement, Aim 1 will expand the search for genes with a high variant load in hearing loss to
include all participants in the NIH All of Us Research Program who have sequence data and to subgroups
selected by race/ethnicity and sex using procedures for analysis of human subjects developed during studies
of our Parent Center cohort and the UK Biobank. Aim 2 will investigate the same set of variants as in Aim 1
using a novel algorithm devised and used for the Parent Center cohort to determine if specific individual
variants are linked to poorer or better pure-tone thresholds as compared to the age- and sex-matched non-
carrier cohort. It is hoped that the increased sample size afforded by the NIH All of Us database will provide a
means to undertake pathway enrichment studies that may lead to the identification of a broad range of target
options at which to direct therapeutics aimed at preventing or slowing the progression of presbyacusis.
Moreover, knowledge gained from this much larger and more inclusive study population about the distribution
of specific variants between males and females and among older adults from different racial/ethnic
backgrounds will facilitate precision medicine approaches for the selection of interventions for the prevention
and treatment of age-related hearing loss.

Public health relevance
PROJECT NARRATIVE The Administrative Supplement to the P50 Clinical Research Center expands the Center’s focus on genetic variants associated with increased susceptibility to human age-related hearing loss by incorporating audiologic and whole genome sequencing data from the highly diverse participants in the NIH All of Us Research Program. Hearing loss is highly heritable, and it is estimated that >1000 genes may underlie this highly prevalent condition, but few have been confirmed in humans. The long-term goals are to reduce the prevalence, slow the progression, and develop new prevention, diagnostic, and treatment strategies to improve the quality of life for millions of older adults with hearing loss.